Nucleus Accumbens-Associated Protein-1 in Melanoma Immunotherapy

PROJECT SUMMARY/ABSTRACT
As melanoma mostly expresses tumor-specific neo-antigens (Ags), immunotherapy such as adoptive cell
transfer-based therapy (ACT) is considered a promising treatment option for this notoriously deadly disease.
Nevertheless, due to various factors that may weaken therapeutic immunity, the clinical outcomes and benefits
of this remedy remain less satisfactory. Importantly, accumulating evidence suggests that the metabolic status
of both immune cells and tumor cells has a significant impact on the potency of ACT, and that metabolic
reprogramming may represent a viable target for reinforcing immunotherapy. Nucleus accumbens-associated
protein-1 (NAC1) is a transcription co-regulator belonging to the BTB/POZ gene family, and is highly expressed
in several types of cancer including melanoma. Published studies including our own have shown that NAC1
not only bestows oncogenic potential but also undermines therapeutic outcomes through its transcription-
dependent or -independent functions. More recently, we discovered that NAC1 can promote glycolysis through
its interaction with HIF-1a, and is critically required for development, survival and function of T cells as well as
tumor cells. We also found that NAC1 negatively affects the tumoral expression of major histocompatibility
complexes (MHCs); the alteration of NAC1 gene expression occurs during differentiation of the pluripotent
stem cell (PSC)-derived T cells, and this alteration is accompanied by changes in the expressions of a number
of other genes. Based on these intriguing findings, we hypothesize that NAC1-mediated metabolic
reprogramming suppresses anti-tumor immunity; targeting NAC1 would hasten death or reduce resilience of
both tumor and suppressor immune cells and modulate the expression of tumor Ags, checkpoint molecules
and the related proteins, thereby relieving immune-suppression and reinforcing the efficacy of ACT against
melanoma. To test these hypotheses, the current multiple PI application proposes the following highly
interactive specific aims: (1) To determine the novel role of NAC1 in T cells; (2) To determine the role of
tumoral NAC1 in melanoma immune escape; and (3) To determine the impact of targeting NAC1 in ACT
against melanoma. This multiple PI project combines the Yang laboratory’s strength in cancer biology with the
Song laboratory’s expertise in tumor immunology. We have already established the mouse and human PSC-
derived antigen-specific CD8+ T lymphocytes, and the murine syngeneic and humanized (NOD-scid IL2rgnull)
mouse melanoma models for the proposed studies, and are well poised to accomplish the above aims.
Completion of this project will not only uncover NAC1 as a unique molecular determinant of tumor-specific
immune responses and shed new light on the importance of NAC1 in cancer pathobiology, but also provide
novel therapeutic opportunities to enhance ACT against melanoma through the NAC1-targeted strategy.

Public health relevance
PROJECT NARRATIVE Melanoma, one of the most aggressive and fatal neoplasms, is responsible for over 80% of skin cancer-related deaths. By determining the role and importance of NAC1, a cancer recurrence- associated gene product and a transcription co-regulator, in regulating antitumor immunity, we propose to design and develop a novel and effective strategy to reinforce immunotherapy for patients with this devastating disease. Thus, this proposal is immediately relevant to “Cancer Moonshot”, and may ultimately have a large impact in improving melanoma treatment.